UniProt - Text Mining and Large Language models to Enhance Functional Annotation in UniProt of Protein Variants Associated with Alzheimer's Disease

Project Summary
Text Mining and Large Language Models to Enhance Functional Annotation in UniProt of Protein
Variants Associated with Alzheimer's Disease
Alzheimer’s Disease (AD) is a common and devastating neurodegenerative disorder that currently
has no effective treatment. Many genetic variants associated with AD have been identified and, in some
cases, the molecular and clinical consequences of these variants have been elucidated and reported in the
scientific literature. As the premier resource for protein sequence and function information, UniProt is in an
ideal position to curate and disseminate this AD variant information to support research on novel therapies.
Here, we propose to use a combination of text mining strategies, including our previously developed
relation extraction tool eMIND, which captures information about the functional impact of variants in AD, as
well as a cutting edge GPT Large Language Model (LLM), to enable high-throughput curation of variants of
high interest to the AD community.
We have previously developed eMIND, a transformer-based text mining system that extracts
relations between AD variants and functional impacts from the literature, and have demonstrated that it has
good performance on a selected set of AD-related abstracts. In this work, we will develop a pipeline to
automatically process PubMed abstracts at full-scale using eMIND and output variant-impact relations as
well as the abstracts and individual sentences from which they were derived. This information will be used
in conjunction with the LLM for several purposes. First, we will use the LLM to create natural language
summaries of the impact of AD-related variants based on sentences and abstracts identified by eMIND
(Aim 1). By focusing the LLM on text already flagged as relevant by eMIND, we will increase accuracy
while taking advantage of the LLM’s ability to synthesize information across sentences from multiple papers
and produce a highly readable product. All summaries will be manually evaluated by expert curators. Next,
we will develop a set of high-confidence variant-impact relations that can be used in applications, such
as knowledge graph representation and learning, that require information in a structured format (Aim 2).
We will use the LLM in two ways: (i) to assess the validity of the relations extracted by eMIND and (ii) to
extract relations de novo from eMIND-positive sentences and abstracts. The results of both approaches will
be manually assessed and compared. Finally, the most relevant relations and summaries of the functional
impact of AD-related variants obtained in Aim 1 and Aim 2 will be made available to users through the
UniProt API and website (Aim 3). We will seek feedback from the AD community about the quality and
presentation of the information.
Taken together, this work will enable scalable curation of AD variant information of high value to the
AD community and serve as a model for a fully automated variant annotation workflow that can be
generalized to other diseases.

Public health relevance
Project Narrative Text Mining and Large Language Models to Enhance Functional Annotation in UniProt of Protein Variants Associated with Alzheimer's Disease Hundreds of genetic variants associated with Alzheimer’s Disease (AD) have been discovered, and better understanding of the impact of these variants is key to developing effective strategies for diagnosing, preventing, and treating AD. However, much of the information about AD-related variants is scattered throughout the scientific literature, so it is challenging for AD researchers to find and piece together this knowledge. To address this problem, we will use a combination of custom-built text-mining tools and Large Language Models (e.g., ChatGPT) to automatically extract information about AD-related variants from the literature, and we will present the results in UniProt in a variety of accessible, user-friendly formats.